EXPOSURE AND IMMUNITY IN PREVENTION OF MYCOBACTERIUM AVIUM INFECTION IN AIDS

The goals of this epidemiological study are to identify environmental sources of Mycobacterium avium complex (MAC) infection in people with AIDS and to identify markers of immunity to this infection.